Extreme temperature, humidity, air pollution and spontaneous preterm birth

PROJECT SUMMARY
This project will extend methods for estimating daily temperature, humidity, and fine particulate matter air
pollution at high resolution across large regions by utilizing NASA and new USGS satellite measurements to
generate estimated exposures at the neighborhood level across the Northeast US. This detailed exposure
record can be used in health studies to further consider extreme weather and air pollutant as a health risk.
These new daily models will be developed for 2007-2023 at a <1 km resolution and thus include billions of
point-day temperature, humidity, and particulate matter estimates. While it is well established that particulate
matter increases the risk of preterm birth, less is known about how extreme weather events (including
temperature and humidity) and air pollution contribute to the onset of spontaneous preterm birth.
Pathophysiology builds throughout a lifetime & during pregnancy, yet the onset of preterm labor and/or rupture
of membranes is acute. In this way, we investigate potential environmental triggers to ask, “Why today?”. The
epidemiologic application of these novel exposure models will be demonstrated by testing the association of
temperature, humidity, and particulate matter with a dataset of spontaneous preterm births and residential
addresses from a comprehensive New York statewide administrative database. We will use address-level
exposures in the 7 days prior to a spontaneous preterm delivery with matched days in the same fixed two-
week period as a comparison (time stratified case-crossover design) for 17 years of spontaneous preterm
births statewide – making this among the largest environmental epidemiology studies of spontaneous preterm
birth with more than 170,000 cases. Given the large number of cases and the variation in population
characteristics across New York State, the association between extreme weather, air pollution patterns and
spontaneous preterm birth will be further tested for effect modification by sex, race, gestational age,
urban/rural, and neighborhood deprivation. A follow-up analysis will use carefully phenotyped spontaneous
preterm cases from large hospital systems in Philadelphia. Our epidemiologic models will improve on prior
work on the acute impacts of extreme temperature and air pollution on preterm birth that have relied on coarse
exposure assignments via ecological time series models, inappropriately long time strata for case-crossover
comparison, or overly broad outcome definitions that included medically-indicated preterm births. Given the
global coverage of satellite remote sensing, our approach – which can generate daily exposure estimates that
are highly spatially resolved (<1 km) to capture ambient exposure at the home address – is broadly applicable
to better understand the role of extreme weather and air pollution as a stressor in both chronic and acute
health outcomes using big data registries.

Public health relevance
PUBLIC HEALTH RELEVANCE Weather extremes and air pollution impact birth outcomes, but the role of combinations of temperature, humidity, and air pollution together is not well understood. We propose to improve methods to estimate local temperature, humidity, and air pollution patterns at residential addresses, and investigate their acute association with spontaneous preterm birth in large datasets. Improving the ability to construct complex spatio- temporally varying environmental exposure estimates will inform future weather and air quality warning systems.